Investigation of ssDNA binding proteins and protein-ssDNA interactions

Project Summary/Abstract Molecular interactions between proteins and single-stranded DNA (ssDNA) play crucial roles in many fundamental biological processes, such as DNA replication, DNA recombination, DNA repair, gene regulation, and genome stability. ssDNA-binding proteins encompass various degrees of binding specificity, ranging from highly specific to non-specific. Despite the critical roles of protein-ssDNA interactions in essential biological processes, the investigation of protein-ssDNA interactions lags far behind other types of protein-nucleic acids interactions, such as protein-double stranded DNA (dsDNA) interaction. Currently there are no comprehensive, well-annotated resources for studying protein- ssDNA interactions. This proposal aims to investigate the mechanism of protein-ssDNA interactions by first constructing well-annotated protein-ssDNA data resources and by performing comparative analysis at two different levels. The first is to compare structural features between protein-ssDNA complexes with different binding specificity. The second is to investigate the similarity/differences between protein- ssDNA and protein-dsDNA complexes. In addition, we propose to predict novel ssDNA binding proteins from the unannotated protein sequences by combining structure-based protein threading methods and sequence-based machine learning approaches.

Public health relevance
PROJECT NARRATIVE This proposal aims to build comprehensive data resources for studying complexes between protein and single-stranded DNA (ssDNA) and to investigate the structure and function of ssDNA binding proteins. Protein-ssDNA interaction is critical in many biological processes and plays essential roles in maintaining genome integrity, promoting genome stability and transcription regulation. The results from this project will help us better understand the landscape of protein-ssDNA interactions.